Core B: Clinical Resource Core

CORE B: SUMMARY/ABSTRACT
The Clinical Resource Core (CRC; Core B) will provide support for human subjects Projects I and III of the
University of Michigan (U-M) Udall Center through recruitment, enrollment, and detailed clinical assessment of
Parkinson disease (PD) subjects and age- and gender-matched control (NC) subjects. A unique feature of the
proposed U-M Udall Center is that it will leverage the unique deeply clinical and neuroimaging phenotyped PD
population from our previous Udall Center (09/2014-08/2020). The cohort of PD subjects comprehensively
assessed in the previous U-M Udall Center cycle will be recruited for additional longitudinal assessments with a
supplemental cohort of new PD subjects. The CRC has standardized methods for data collection, entry, and
verification, as developed by the Biostatistics and Data Management Core (BDMC; Core D), compliant with
HIPAA and IRB regulations. Data collected is consistent with NINDS Common Data Elements to facilitate transfer
of data to the NINDS Data Management Repository using ProFORMS. The CRC will closely collaborate with the
Neuroimaging Resource Core (NRC; Core C) to coordinate in vivo neuroimaging assessments of subjects.
The CRC will serve as the liaison between Project III and the investigators of the Dutch Parkinson and
Cognition (DUPARC) study at the University of Groningen (P.I. Dr. Teus van Laar). The CRC will continue to
foster existing collaborations with the Pacific Udall Center (P.I. Dr. Thomas Montine) and the University of
Rochester Udall Center (P.I. Dr. Ray Dorsey). The specific goals of the CRC are:
1. To recruit, enroll, and retain PD subjects (net enrollment target of N=100 eligible PD subjects) and age- and
gender-matched NC subjects (N=20) for the U-M Udall Center Projects I and III in support of their scientific
goals.
2. To comprehensively assess all subjects with well-established clinical, motor function, and
neuropsychological instruments at baseline and follow-up.
3. To provide the organizational structure and operations oversight for the U-M Udall Center Projects I and III
and interact and coordinate with other Cores to assure prompt neuroimaging assessment (NRC) and data
transfer and analysis (BDMC).
4. Facilitate and coordinate data transfer from the University of Groningen DUPARC study.
5. Support existing collaborations with other Udall Centers and facilitate transfer of data to and from these Udall
Centers